Selecting sperm with distinct metabolic phenotypes to increase ART efficiency

PROJECT SUMMARY/ABSTRACT
More than 80,000 births in the US occur annually as a result of assisted reproductive technology (ART). The
success of ART typically requires multiple expensive cycles that together exceed many US families’ yearly
household incomes. The necessity of multiple ART cycles stems in part from an insufficient number of healthy
preimplantation embryos. Healthy embryos are a direct product of the highest-quality gametes, yet limited
methods exist to identify the highest-quality sperm. Within the female reproductive tract, sperm with the highest
fertilization competence are naturally selected based on functional parameters – motility patterns, chemotaxis,
and the acrosome reaction. The best fertilization-competent sperm also have the lowest levels of oxidative and
DNA damage. Unfortunately, current clinical methods for selecting sperm for intracytoplasmic sperm injection
(ICSI) do not leverage these parameters. The broad objective of this application is to define the biochemical
mechanisms by which sperm undergo motility switching and fertilization competence, and results will both
advance the state of basic knowledge and enable optimization of in vitro sperm selection techniques. The
optimization of sperm selection for ART will in turn: 1) increase production of healthy embryos; 2) reduce average
numbers of costly cycles; and thus 3) lessen the cost burden on lower-income families. In Aim 1, we will utilize
complementary comprehensive bioenergetic phenotyping, computer assisted motility analysis (CASA), and a
novel dehydrogenase screen to define the underlying mechanisms through which metabolites predictably
modulate the essential motility patterns of mouse sperm. In Aim 2, we will test the hypothesis that predictable
motility changes in response to metabolites can be used to select the best mouse sperm – those with normal
morphology and low levels of DNA damage, the ability to navigate towards a chemotactic signal and initiate
hyperactive motility, and complete the acrosome reaction. We will then employ in vitro fertilization (IVF) to
determine whether mouse sperm selected based on these metabolism-based motility traits have enhanced ability
to generate healthy embryos. In Aim 3, we will exploit our experience working with mouse sperm to define the
fundamental differences in the metabolism-based motility responses of human sperm. This project is expected
to identify the mechanisms connecting microenvironment to sperm function and thereby provide proof-of-concept
for the rapid development of methods to optimize clinical selection of fertilization-competent human sperm for
ART.

Public health relevance
PROJECT NARRATIVE Following intercourse, the best sperm is naturally selected as the one that first successfully traverses the distinct biochemical microenvironments within the female reproductive tract. By mimicking these diverse biochemical microenvironments within the female reproductive tract and understanding how sperm motility should be accordingly modified, we can help clinicians identify the best sperm for IVF. This will increase production of healthy embryos and thus reduce the number of costly IVF cycles, easing the financial burden and making these procedures more accessible to low-income couples.